Computational Modeling of Ambiguity Aversion in Internalizing Disorders: Neural and Behavioral Markers, and a Test of Target Engagement

PROJECT SUMMARY
Uncertainty is a part of daily life, but those with difficulty tolerating uncertainty are at risk for anxiety-related and
other internalizing disorders. A key contributor to difficulty with uncertainty is an elevated aversion to choices
that have ambiguous outcomes (aka ambiguity aversion [AA]). Studies, however, have not tested (a) AA as a
transdiagnostic dimension of internalizing psychopathology, and (b) the time course of the brain’s
responses to ambiguous choices. This study thus uses computational modeling, electrophysiology, and a
novel experimental manipulation to test whether AA is a behavioral and neural mechanism of internalizing
psychopathology in a transdiagnostic sample of 140 adult participants with moderate to high intolerance of
uncertainty. We will test whether computational parameters of behavioral AA (Aim 1) and event-related potentials
[ERPs, neurophysiological markers with millisecond resolution) to ambiguity (Aim 2) exhibit convergent validity
(associations with anxiety and depression dimensions, intolerance of uncertainty) and discriminant validity
(lack of associations with sensation seeking). Aim 3 will further test AA as a mechanism of internalizing disorders
by testing whether an experimental manipulation (i.e., a brief behavioral intervention) “moves” AA. This
experimental approach not only provides a robust test of AA as a mechanism within internalizing
psychopathology, but also informs future clinical trials that could, for example, use an uncertainty-focused
intervention as an adjunct treatment to existing interventions. These aims are novel in two additional ways. First,
collecting ERPs related to AA is novel and cost-effective (relative to prior neuroscience studies which have used
fMRI), and will provide insight about the time course about the brain’s responses to ambiguity (e.g., whether AA
is driven by early [i.e.,~100ms], or later [after 300ms] reactions to ambiguity). Second, while past studies have
examined AA in only single disorders, this project will examine associations with transdiagnostic dimensions that
theoretically relate to AA (convergent validity) and dimensions that should theoretically not relate to AA
(discriminant validity), a rigorous approach that will ultimately have larger clinical impacts. In sum, this project
has the potential to identify a transdiagnostic intervention target using an easily administered behavioral and
brain assessment of AA, a goal that is directly in line with NIMH’s Strategic Objectives. This K23 will also provide
the applicant with the training and mentored research experience necessary for his long-term goal of studying
disrupted brain and computationally-derived behavioral mechanisms of internalizing disorders. Training will focus
on 1) computational modeling of decision-making behavior, 2) experimental target engagement approaches to
interventions, 3) advanced electrophysiological methods and dimensional, transdiagnostic “RDoC” models of
psychopathology, and 4) development of grantsmanship, lab management and mentorship skills. This training
will be conducted at Northwestern University and facilitated by a team of experts in computational,
psychophysiological, and therapeutic approaches, all studying mechanisms of change in internalizing disorders.

Public health relevance
PROJECT NARRATIVE As highlighted by the COVID-19 pandemic, ambiguous situations are highly aversive, and exert a powerful influence on mental health; for example, too much avoidance of or aversion to ambiguity has been tied with internalizing disorders (e.g., depression and anxiety-related disorders). This project aims to use computational modeling of decision-making behavior, psychophysiology, and an experimental manipulation to test whether ambiguity aversion is a behavioral and neural mechanism of internalizing disorders. By using multiple methods, this study will help clarify whether abnormal levels of ambiguity aversion contribute to internalizing psychopathology, and how targeted behavioral interventions have the potential to decrease ambiguity aversion.